Project 2

PROJECT 2 SUMMARY
Immune checkpoint inhibitor (ICI) adjuvant therapies—including ipilimumab (IPI; targets cytotoxic T lymphocyte-
antigen 4) and nivolumab (NIVO; targets programmed death protein 1)—increase relapse-free survival (RFS) in
melanoma patients. Nonetheless, 35–40% of these patients relapse within 24 months after completing ICI
therapy, and no biomarkers—either alone or together—can predict RFS after ICI therapy and potentially identify
novel targets for more effective adjuvant treatments. Efforts to identify biomarkers of ICI efficacy have centered
mainly on the tumor microenvironment in the metastatic setting, leaving putative biomarkers of adjuvant ICI
treatments largely unexplored. Because anti-tumor T-cell immunity is the primary target of ICI, the focus has
been predominantly on tumor T-cell infiltration. Here we propose the novel hypothesis that underlying
inherited factors that influence host immunity impact RFS after adjuvant ICI. It has been demonstrated that
phenotypic variation in T-cell subsets, including CD8+ T cells, can be attributed to germline genetic variation. In
a recent study, we showed that this inherited component maps to the non-coding regulatory genome, impacting
transcriptional regulation of T-cell differentiation and function. Based on these data, we hypothesize that germline
genetic variation in the T-cell-specific non-coding regulatory genome (regulome) controls circulating CD4+ and
CD8+ T cells (the primary targets of NIVO and NIVO+IPI ICI), and that this genetic variability is associated with
RFS after ICI treatment. We propose to discover inherited signatures of the CD4+- and CD8+- T-cell regulome
that predict ICI relapse and RFS. Using samples from 600 melanoma patients treated in an adjuvant clinical trial
of NIVO compared to NIVO+IPI, we will perform whole-genome (WGS) and whole-transcriptome sequence
analyses of CD4+ and CD8+ T cells from peripheral blood collected before ICI treatment to identify non-coding
transcriptome signatures that predict RFS after adjuvant ICI (Aim 1). We will also comprehensively assess open
chromatin states in pre-treatment CD4+ and CD8+ T cells from the same 600 patients to identify epigenetic
signatures controlled by inherited genetic variation, and predict RFS after adjuvant ICI (Aim 2), and integrate
these data with microbiome, immuno-phenotyping, and seromics profiles from Project 1 (Aim 3). Our preliminary
data have revealed novel genomic imprints in the non-coding regulome that predict ICI response with high clinical
accuracy, thus substantially supporting our hypotheses and study design. For the first time, we will elucidate the
effect of inherited anti-tumor host immunity on ICI outcomes in the adjuvant setting. Besides having applicability
to personalized prediction of ICI benefit, the integration of genomic information from all three aims of this project
promises to reveal novel T-cell-specific transcriptional networks that potentially affect ICI resistance and might
serve as targets for improved adjuvant ICI therapies in melanoma and other cancers.

Public health relevance
PROJECT 2 NARRATIVE A substantial number of patients do not benefit from promising new immune checkpoint inhibitor therapies that stimulate the immune system to target melanoma. In our study, we propose to discover the genomic factors in host immune cells that influence response to these novel therapies, providing an opportunity to significantly improve treatment and survival outcomes for patients with melanoma.